Linking memories through hippocampal ensemble reactivation

Project Summary
Post-traumatic stress disorder (PTSD) is a debilitating condition characterized by persistent and
intrusive memories of a traumatic event. Understanding the mnemonic processes through which fear
is triggered by environmental stimuli is therefore paramount to PTSD treatment. That said, the most
widely employed models of associative fear conditioning used to study PTSD only assess cues
directly paired with an aversive event and do not capture the spread of fear beyond these stimuli. This
represents a critical gap in our knowledge of the etiology of the disorder. This proposal seeks to
increase our understanding of how aversive memories propagate to other memories and could
fundamentally change our view of how fear spreads in PTSD. We recently demonstrated that when
animals are exposed to two neutral environments within several hours of each other they are capable
of being linked in memory (they activate overlapping cell populations), providing a tool for
understanding how events across time come to be related. Moreover, we found that when one of
these environments was subsequently paired with an aversive event, fear spread to the linked
(neutral) environment as well, providing a novel mechanism for the spread of fear. However, it is
unknown how strength of an aversive experience affects the propensity for memories to be linked.
Moreover, it is unknown how neuronal activity after learning supports the integration of distinct
episodic memories. I have collected extensive preliminary data suggesting that aversive events are
able to extend the window of linking, such that fear is transferred from an aversive event to a neutral
memory formed days before. These findings are remarkable because they could potentially explain
how so many stimuli come to trigger PTSD symptoms. The unifying goal of this proposal is to
understand how aversive experience links distinct memories encoded across days, and to identify a
circuit mechanism that explains how this occurs. In the first aim, I will examine how the strength of
aversive experience modifies the ability of stimuli to be linked across time, while simultaneously
imaging calcium dynamics in the hippocampus, a brain structure known to be altered in PTSD. I will
record during learning, the period directly following learning, and retrieval of neutral and aversive
experiences. In the second aim, I will selectively inhibit the hippocampal ensemble of the neutral
memory after learning of the aversive experience. This will enable me to test whether co-reactivation
of the neutral- and aversive-encoding ensembles in the hippocampus after learning is necessary for
the two experiences to become linked in memory. Integrating advanced behavioral assays, in vivo
calcium imaging, and cell-specific neuronal manipulation strategies, this work promises to shed light
on how fear spreads in PTSD, and how this spread might be prevented.

Public health relevance
Project Narrative The symptoms of Post-Traumatic Stress Disorder (PTSD) are often elicited by environmental stimuli that were not directly present during trauma; thus, understanding how fear is generalized to non- trauma associated stimuli is paramount to developing effective PTSD treatment. We have found that the temporal linking of memories permits the spread of fear to neutral stimuli occurring days prior to an aversive event. The experiments in this proposal will leverage cutting-edge technologies to understand how neuronal activity after learning binds memories encoded across time in an effort to advance novel treatments for PTSD.